Administrative Supplement for NCI P30 CCSGs to extend partnerships with comprehensive cancer control coalitions to study implementation of evidence-based cancer control interventions

Abstract The UNC Lineberger Comprehensive Cancer Center (LCCC) serves all North Carolina (NC) residents by conducting research and translating research findings into practice focused on North Carolinians’ needs and by ensuring that high quality, accessible cancer care is provided to all who need it. Since receiving NCI cancer center designation in 1975 and comprehensive status in 1990, LCCC has served as the only public comprehensive cancer center in NC with patients, outreach, and research efforts in all 100 NC counties, which led to the entire state being defined as LCCC’s catchment area. Racially/ethnically diverse and rural populations in NC face a disproportionate burden of cancer and are key constituent populations for LCCC efforts. For decades, LCCC-supported research and outreach efforts have been committed to implementing practices and policies that are evidence-based and designed to address specific needs in the catchment area, particularly in racial/ethnic minority and rural populations; these responsibilities are now coordinated by the LCCC Community Outreach and Engagement (COE) Office. Evidence-based interventions (EBIs) to reduce high-risk behaviors and improve early detection, treatment, survivorship, and health outcomes for patients with disproportionately high cancer burden clearly exist but are underutilized. These strategies include, but are not limited to, evidence-based strategies to reduce tobacco use and improve HPV vaccination, cancer screening uptake, navigation to cancer treatment, regular symptom monitoring, and linkage to comprehensive survivorship support and palliative care. Funds are needed in the community to build capacity and stimulate implementation of such EBIs in practice across a diversity of NC settings. The Putting Public Health Evidence in Action training curriculum and toolkit is an existing resource developed by public health scholars and practitioners within the Cancer Prevention and Control Research Network (CPCRN) and Comprehensive Cancer Control Collaborative of NC (4CNC) to enhance EBI implementation through provision of standardized training, tools, and technical assistance. In this application, our COE Office proposes to partner with the CPCRN, 4CNC, the NC Division of Public Health’s Cancer Prevention and Control Branch, and the state’s Community Cancer Network (CCN), comprised of community cancer-focused organizations and stakeholders, to: (1) deliver the Putting Public Health Evidence in Action training to CCN members across the state to develop community capacity to identify, adapt, and implement cancer prevention and control EBIs in their communities, and (2) launch and evaluate a community pilot grant program to support and sustain EBI implementation. Competitive community proposals will address a specific community cancer need, focus on an existing EBI or set of EBIs, receive ongoing technical assistance from COE, CPCRN, and 4CNC and focus on meaningful sustainment of EBIs beyond the funding period to reduce cancer burden and disparities.

Public health relevance
Project Narrative For decades, the UNC Lineberger Comprehensive Cancer Center (LCCC) has championed statewide, community-based efforts committed to the translation of evidence-based research into practice, particularly in racial/ethnic minority and rural populations who shoulder a disproportionate burden of cancer in North Carolina (NC); these responsibilities are now coordinated by the LCCC Community Outreach and Engagement (COE) Office. Community organizations have only limited capacity to adopt and implement evidence-based interventions EBIs in practice, and levels of capacity are often lowest in settings that serve racially/ethnically diverse and rural populations. In this application, we propose to build capacity in NC community organizations to implement and sustain EBIs in practice through disseminating the existing Putting Public Health Evidence in Action curriculum and launching a small grant program to support community organization-level EBI implementation, building upon existing partnerships among the COE Office, the Cancer Prevention and Control Research Network, the state Division of Public Health’s Cancer Prevention and Control Branch and its Community Cancer Network, a statewide coalition of community-based, faith-based, tribal, public health, and clinical organizations.